INFORMATICS CORE

As a leading-edge academic provider of Biomedical Informatics services, the ADCS Informatics Core strives to develop and deploy innovative methods and solutions that enhance data capture, data integrity and validity, ensure regulatory compliance, and support the efficient completion of research objectives thus accelerating the rate of scientific discovery and optimizing return on research investment. The staff of the Informatics Core has extensive experience providing informatics services to facilitate the conduct of multi-site randomized clinical trials and observational studies.

Public health relevance
the Informatics Core will provide informatics services to selected extra-ADCS projects, such as the Alzheimer's Disease Neuroimaging Initiative (ADNI) and the Dominantly Inherited Alzheimer's Network (DIAN), that are deemed to be significant contributions to the advancement of Neuro/AD research.